Role of ICAM1 in development and progression of pancreatic cancer

PROJECT SUMMARY/ABSTRACT
Pancreatic ductal adenocarcinoma (PDA) carries a dismal prognosis. Understanding the mechanisms that lead
to the development and progression of PDA in order to identify novel methods of intervention is the greatest
hope for prevention and treatment. Animal models have shown that the development of pancreatic cancer is
driven by two events, the acquisition of an oncogenic mutation in KRas and pancreatic inflammation. Our
previous work demonstrated that oncogenic KRas upregulates a soluble form of ICAM1 (sICAM1), which acts
as chemoattractant for inflammatory macrophages (M1) to initiate the formation of pancreatic lesions. We also
have shown that pancreatic lesions, by releasing IL-13, can crosstalk with M1 macrophage populations in order
to induce their polarization to an alternatively-activated phenotype (M2) that is tumor promoting. This proposal
focusses on understanding the mechanism of how macrophages are attracted by precancerous lesions, but
also on how their conversion into tumor-associated macrophages can be prevented. It is our hypothesis that
KRas-driven expression of ICAM-1 is a regulator of macrophage populations and its targeting can have
major effects on development and progression of pancreatic cancer. To test this we will: determine how
oncogenic KRas leads to formation of a soluble form of ICAM1 (Specific Aim 1); determine the roles of MMP3
and ICAM1 in attracting inflammatory macrophages (Specific Aim 2); To determine the in vivo function of
MMP3 with respect to production of sICAM1, chemoattraction of macrophages and development of PDA
(Specific Aim 3); and test an ICAM1 targeting strategy alone, and in combination with current chemotherapy
or modulators of the tumor microenvironment (Specific Aim 4). Successful completion of our project will
demonstrate the importance of KRas-induced expression and processing of ICAM1 for the development and
progression of pancreatic cancer, but also lead to novel strategies to keep macrophages absent, and thus halt
desmoplasia, lesion progression and metastasis.

Public health relevance
PROJECT NARRATIVE The crosstalk between KRas mutations and inflammatory processes drive the development and progression of pancreatic cancer. Here we will investigate the mechanisms of how oncogenic KRas mediates the attraction of macrophages and how this contributes to development of cancer, but also test novel approaches to block this event. Overall our project will lead to preclinical data supporting new treatment strategies that can be incorporated into standard of care treatment and may lead to a better outcome for patients with advanced cancer.